Engineered Intravascular Catheters for the Treatment of Bacteremia

DESCRIPTION (provided by applicant): Engineered Intravascular Catheters for the Treatment of Bacteremia Most patients undergo intravascular catheter placement at some time during their hospitalization, Ensuing infection is the most common complication associated with intravascular devices and subsequent bacteremia can be a highly morbid and oftentimes lethal consequence. In this project, we will apply the principle of phase-boundary catalysis in catheter design and test ability of engineered intravascular catheters in preventing infections and treatment of bacteremia on animal models.

Public health relevance
PUBLIC HEALTH RELEVANCE: Engineered Intravascular Catheters for the Treatment of Bacteremia The traditional approach for treating an intravascular catheter infection has been catheter removal, administration of parenteral antibiotic(s), and replacement of the catheter at a separate site. Patients suffer severe discomfort. The goal of this research is to study the ability of engineered intravascular catheters in preventing infections and treatment of bacteremia.